Mechanism of PRC2-mediated Gene Silencing during Cardiomyocyte Differentiation

Project Summary
Cardiomyocytes require precise gene regulation programs to prevent pathophysiology. Upregulation of cardiac
remodeling genes results in cardiomyocyte hypertrophy and decreased heart function. While much is known
about the transcription factors that drive cardiomyocyte specific gene expression, we have a limited
understanding of how histone posttranslational modifications regulate cardiomyocyte development and
maintenance. Polycomb Repressive Complex 2 (PRC2) is a histone modifying complex that silences gene
expression by tri-­methylating lysine 27 on histone H3. Conditional knockout studies show the absence of
PRC2, during mouse heart development, results in upregulation of cardiomyocyte specific transcription factors
and cardiac hypertrophy. However, there is a lack of mechanistic understanding regarding how PRC2
regulates cardiomyocyte specific genes. Emerging evidence demonstrates that human PRC2 is recruited to
chromatin through an interaction with a set of accessory proteins known as AEBP2 and PCL proteins. This
proposal will utilize PRC2 separation-­of-­function mutations to test the hypothesis that the interaction between
PRC2 and these accessory proteins is necessary for regulating cardiomyocyte specific genes and for
preventing cardiomyocyte hypertrophy. High-­throughput sequencing and immunocytochemistry approaches
will be used to determine whether AEBP2 or PCL proteins is/are responsible for maintaining the transcriptional
profile and phenotype of cardiomyocytes in a PRC2 dependent manner. Furthermore, live-­cell single-­molecule
imaging will be used to define how AEBP2 and PCL proteins affect the chromatin-­binding dynamics of PRC2
throughout cardiomyocyte differentiation. The experiments in this proposal represent a critical step toward
uncovering the mechanism of PRC2 mediated gene-­silencing in cardiomyocytes, a mechanism that is central
to normal heart development and function.
Training Plan Summary: The proposed research will be completed in the University of Colorado Boulder
Biochemistry Department, located in the multidisciplinary BioFrontiers Biotechnology building. The applicant
will draw from local expertise in the fields of cardiomyocyte biology, computational biology, chromatin biology,
and transcriptional regulation to develop into an independent physician-­scientist that is well versed in
mechanisms of gene regulation. The applicant’s training plan includes taking coursework, receiving individual
mentorship, attending conferences, giving oral presentations, and preparing/submitting manuscripts.

Public health relevance
Project Narrative This proposal will study how Polycomb Repressive Complex 2 regulates cardiomyocyte specific gene expression. Findings generated from the proposed aims will expand our understanding of a mechanism that governs proper heart development, function, and could provide pathways for future cardiomyopathy therapies.